MOPP VERSUS RADIOTHERAPY FOR EARLY STAGE HODGKIN'S DISEASE

This study was designed to compare the response rates and toxicities of MOPP chemotherapy vs radiation in the management of previously untreated laparotomy-documented patients with early stage Hodgkin's disease. Of the 55 evaluable patients randomized to MOPP, 53 (96%) achieved complete response; 7 relapsed. Fifty of the fifty-two randomized radiation-treated patients (96%) achieved a complete response: 19 patients (38%) relapsed. Four MOPP-treated patients (7%) and eleven (21 %) radiation-treated patients have died.